The effects of neural modulation on phonatory function in laryngeal dystonia

Project Summary
This application will provide the Principal Investigator, Dr. Teresa Kimberley, with protected time and
support to (1) accelerate a successful record of mentoring junior investigators; (2) provide research
training to mentees engaged in patient-oriented communication disorder research; (3) enhance
training in assessing voice production and; (4) advance the translation of Dr. Kimberley's ongoing
research on laryngeal dystonia. Dystonia is a group of devastating neurological movement disorders
that can affect any body region. There is no cure or disease-modifying treatment and the
pathophysiology of the disorder remains largely unknown. The most common dystonia affecting the
vocal fold muscles is adductor laryngeal dystonia (AdLD). People with AdLD suffer from a strangled
voice and speech interruption due to involuntary spasms of the thyroarytenoid (TA) muscles. The long-
term goal of this award is to elucidate the pathophysiology of laryngeal dystonia and to develop
sensitive testing and novel interventions to treat the disease. The proposed project builds upon Dr.
Kimberley's cutting-edge work of developing a novel and valid transcranial magnetic stimulation (TMS)
methodology to assess the cortical excitability of the laryngeal motor cortical area. Recent findings have
shown an atypical pattern of brain activation and decreased intracortical inhibition in people with
AdLD. The hypothesis is that a 5-day inhibitory rTMS protocol targeted to the left laryngeal motor
area associated with the TA muscles will increase intracortical inhibition and improve phonatory
function in people with AdLD. Individuals with AdLD will participate in a randomized, double-blinded,
sham-controlled, preliminary trial. The primary tests will include assessments of phonatory function
(Aim 1) and TMS-measured neurophysiology (Aim 2). Factors associated with positive response to the
intervention will also be explored (Aim 3). This project offers a unique opportunity for mentees to train
in clinical and translational research that is at the intersection of corticobulbar neurophysiology, non-
invasive neuromodulation, and clinical assessment of voice disorders. The rich resources at
Massachusetts General Hospital, MGH Institute of Health Professions, and Spaulding Rehabilitation
Hospital provide an outstanding scientific environment to train the next generation of researchers in
an interdisciplinary approach to communication disorders research. This project has the potential to
positively impact people with AdLD by expanding treatment options, improving quality of life and
reducing healthcare burden for people with this disorder. The knowledge gained from the proposed
study will extend to future research to optimize neuromodulatory interventions, explore rTMS as an
adjunct therapy to current treatments, and to determine if rTMS can be translated to other voice
disorders or types of focal dystonia.

Public health relevance
PROJECT NARRATIVE Adductor laryngeal dystonia (AdLD) is a disorder that causes uncontrolled spasms of the `vocal cords' during speech, causing severe speaking difficulty and a reduction in quality of life. Although the cause of the disorder is not fully understood and there are no treatments for AdLD that produce long-term benefits, our recent findings have discovered that AdLD is associated with a lack of neural inhibition that may be linked to the spasms. The current study builds on these findings to determine if repetitive transcranial magnetic stimulation (rTMS) is effective for increasing neural inhibition, enhancing voice function and improving quality of life for people with AdLD and other voice disorders or types of dystonias.